Indiana University (IU) Clinical Center for Chronic Pancreatitis Clinical Research Network

PROJECT SUMMARY / ABSTRACT
Chronic pancreatitis (CP) is a progressive disease, often leading to loss of exocrine and endocrine
function and debilitating abdominal pain. It is unknown why some individuals progress and
develop complications, including pancreatogenic diabetes (T3cDM) and/or pancreas cancer
(PDAC). In this Consortium, investigators have proposed and initiated several well-powered
studies of risk factors, environmental influences, and proof-of-concept studies to move the field
forward. While two cohort studies are ongoing (PROCEED and INSPPIRE-2), we offer new
innovative proposals to address other research objectives identified by the NIDDK. We propose
several specific aims (SA) to meet the goals of RFA-DK-25-019. In SA #1, we propose to continue
the CPDPC’s two main longitudinal studies: PROCEED, INSPPIRE 2. In SA #2, we offer a
proposal that builds upon the success of our ancillary study, MINIMAP, completed during the last
funding cycle. We will validate MRI and novel criteria as biomarkers for the diagnosis of and
progression to CP using the PROCEED cohort. SA #3: Galectin-3 (Gal-3) is a carbohydrate-
binding protein which appears to be involved in fibrogenesis and tissue remodeling in CP. A Gal-
3 inhibitor is safe and shows potential for reducing hepatic fibrosis in non-alcoholic steatohepatitis.
We propose to test the hypothesis that a Gal-3 inhibitor is safe and efficacious in patients with
CP, and may reverse or halt the fibrosis observed in CP. We will evaluate changes in pancreatic
fibrosis as assessed by MRI, as well as serum and pancreatic fluid exploratory biomarkers. In SA
#4, we propose innovative studies evaluating different strategies and interventions focused on
alleviating abdominal pain in CP patients. Lacosamide, an anti-epileptic drug, appears to inhibit
opioid-induced hyperalgesia. In SA #4a, we will perform a phase-2 double-blind placebo-
controlled trial evaluating the efficacy of adding lacosamide to opioid therapy for change in pain
control, opioid use, and quality of life for patients with painful CP. SA #4b: Quantitative sensory
testing (QST) uses electrical and pressure stimulation at different dermatomes in order to unravel
the pain system. Endoscopic ultrasound (EUS) with celiac plexus block can be an effective
intervention for alleviating pain attributable to CP. We will investigate: (i) QST profiles,
demographic and clinical characteristics in patients with painful CP referred for EUS celiac plexus
block; (ii) whether the QST profile can be used to predict the clinical outcome of EUS celiac plexus
block.

Public health relevance
NARRATIVE Chronic pancreatitis (CP) is a progressive, unrelenting disease, often leading to loss of exocrine and endocrine function and debilitating abdominal pain, resulting in significant healthcare costs. The Consortium for the study of Chronic Pancreatitis, Diabetes and Pancreatic Cancer (CPDPC), formed in 2015, has been tasked with undertaking comprehensive clinical, epidemiological, and biological characterization of patients with CP (including adults and children with acute recurrent pancreatitis) to develop treatments and gain insight into the pathophysiology of CP and its sequela: chronic pain, pancreatic exocrine and endocrine insufficiency, and the diabetes/pancreatic cancer association. The Indiana University clinical center pledges to continue its contribution to ongoing studies by participating in the Chronic Pancreatitis Clinical Research Consortium (CPCRC), and propose additional ancillary studies which will be described herein.